A Project to Test the Efficacy and Safety of An Innovative Treatment for Opiate Use Disorders.

Project Summary/Abstract
This project is to demonstrate that a novel treatment for opiate addiction, as defined by DSM 5,
is safe and far superior to a sham comparison treatment when used as a stand-alone treatment.
The treatment is hoped to significantly aid in the battle against the opiate epidemic that is
ravaging much of our country and the world. The treatment consists of using a 4-minute
application of unilateral transcranial photobiomodulation, near infra-red mode, through a
supra-luminous LED, to one side of the forehead over the brain hemisphere that we determine
(through a proprietary test) to have a more positive emotional valence. Based on robust
preliminary data, including a completed, published Phase I study, we anticipate that the
treatment will be very effective in reducing drug use and relapses as well as cravings, and overall
clinical state and functioning. Aim I will offer once or twice weekly (in equal numbers)
treatments to two groups, active and sham, for 25-weeks with 1 weekly follow-up and will look
specifically for differences in opioid abstinence, opioid use, cravings, and general psychological
and functioning state. All the patients will be using opioids at enrollment and will be on no
opioid use disorder treatment. We will evaluate patients closely for safety and efficacy during
the study. In Aim II we will work with to develop LED devices that pass regulatory requirements
and apply for an FDA breakthrough treatment designation. We will work with the FDA toward
achieving eventual approval for this treatment of opioid use disorder. MindLight’s executive
team will work closely with Garrett Technologies, Inc. business and engineering personnel, to
achieve eventual, successful commercialization so that the novel treatment might become widely
available to those in need. The therapy is based on hypotheses from the MindLight founder’s
psychological theory, Dual-Brain Psychology, and published experiments have well supported
those theories.

Public health relevance
Project Narrative We will test, for safety and efficacy, a novel treatment for opiate addiction that applies a 4- minute treatment of intense near infra-red light to stimulate a side of the brain that we determine to be healthier, more mature, and less traumatized. We will compare among actively using participants an active and a sham treatment given either once or twice weekly for 25- weeks at 2 sites. We hope this will lead to a significant weapon in the battle against the opioid epidemic as well as lead to psychological and physiological insights into possible relations among trauma, cerebral laterality, and addiction.